Microchemistry and Proteomics

ABSTRACT
The Microchemistry and Proteomics (MCP) Core provides mass spectrometric sequencing and quantitation
of peptides and proteins to support basic, translational, and clinical research programs at MSK. The
Core utilizes modern high-resolution mass spectrometry and nanoscale liquid chromatography in
conjuction with biochemical processing of samples with the end goal of determining the identity, relative
abundance, and presence of post translational modifications from purified components, cell lysates,
tissues, and select fluid such as cerebral spinal fluid. Proteins and post translational modification are
critical components of complex signaling pathways underlying development, cell growth, differentiation,
DNA repair, senescence, immune response to cancer, and response to bioactive therapies. Dissection of
these pathways can lead to insights on the underlying molecular mechanisms involved in cancer. The goal of
the MCP Core is to be an efficient, user friendly, state-of-the-art facility. Advice is provided by the Core staff
to facilitate the design, execution, and analysis of experiments.